Epigenetic & Genomics Core

Summary
A major goal in diabetes research is to understand how alterations in the epigenome and subsequent re-
sponses in gene expression impact disease phenotype and treatment regimens. The objective of the Epi-
genetic and Genomics Core (EGC) is to provide cutting-edge, reliable and innovative genomic technolo-
gies to support the diabetes and related endocrinology and metabolism research goals of DRC investiga-
tors. It also offers training, education and consultation in genomics technologies in order to enhance the
ability of DRC Investigators to implement these technologies in their research. The EGC will provide the
following services:
Technical Support For Sequencing-Based Assays: The Core will provide technical support for high-
throughput sequencing assays on Illumina sequencing platforms (MiSeq, NovaSeq X Plus), enabling
RNA sequencing (RNA-seq), microRNA sequencing (miRNA-seq), Chromatin Immunoprecipitation linked
to massively parallel sequencing (ChIP-Seq), Assay for Transposase-Accessible Chromatin with high
throughput sequencing (ATAC-Seq), Cleavage Under Targets-based assays (CUT&RUN, CUT&Tag),
protein-RNA interactions (CLIP-seq), genome-wide chromosome conformation capture (Hi-C), sequenc-
ing of CRISPR Screens and massively parallel reporter assays (MPRAs), as well as Whole-Genome Se-
quencing (WGS).
Single Cell Sequencing Assays: The Core will provide technical support for single cell sequencing as-
says, including 10X Genomics Chromium Single Cell Solution technologies, and implementation of new
technologies as they arise.
Spatial OMICS: The EGC will provide technical support for in situ spatial transcriptomics and protein
measurements in tissue sections (spatial OMICS) based on the 10X Genomics Visium HD and 10X Ge-
nomics Xenium workflows, as well as implementation of new technologies as they arise.
Training and Consultation: The Core will offer consultation and training of students, postdoctoral fel-
lows, investigators and technical staff regarding high-throughput sequencing methodologies and data
analysis, both in the form of individual one-on-one meetings as well as in a technical seminar series or-
ganized by the Core.
Bioinformatics Support: The Core will provide bioinformatics support for assistance with experimental
design, choice of technological platform, data analysis and data quality control.